Role of Striatal Molecular Rhythms in Sleep and Opioid Use Disorder

PROJECT SUMMARY
Opioid use and deaths from overdoses have skyrocketed in the United States over recent years. Most people
with opioid use disorder (OUD) relapse within weeks to months despite treatment. Relapse vulnerability is
strongly associated with severe and persistent sleep and circadian rhythm disruptions, suggesting therapeutics
that mitigate these alterations during withdrawal and abstinence may reduce craving and risk for relapse.
However, our understanding of the mechanisms across cellular and molecular levels in the brains of people with
OUD is extremely limited. We recently demonstrated alterations in several pathways related to dopamine, opioid,
and glutamate signaling in human brain associated with OUD. We also reported significant disruptions in
molecular rhythms associated with OUD in human striatum, encompassing major neural substrates for reward
and motivation, as well as arousal, sleep, and circadian rhythms. We and others developed a novel and
innovative approach for using time-of-death (TOD) of the subject to measure molecular rhythms in human
postmortem brain associated with various psychiatric disorders, gaining insights into disease-specific
neurobiological mechanisms and pathways in human brain. In this proposal, we will use TOD computational
tools combined with single nuclei RNA-sequencing (snRNA-seq) to investigate the relationship between
molecular rhythm disruption in specific cell types of the striatum (nucleus accumbens (NAc), caudate, putamen)
in OUD using postmortem brains from unaffected subjects and subjects with OUD, followed by mechanistic
studies using brain region- and cell type-specific ablation of molecular rhythms in mouse models of opioid self-
administration. In Aim 1, we will use snRNA-seq and TOD analyses to create a cell type specific map of
molecular rhythms in subregions of human striatum. In Aim 2, we will compare molecular rhythms in specific cell
types of the striatum from unaffected subjects to molecular rhythms in cell types from subjects with OUD to
determine the extent of molecular rhythm disruptions associated with OUD at the cellular level. Results will be
integrated with human GWAS sleep and opioid traits. snRNA-seq findings will be validated using in situ
RNAscope hybridization of the top rhythmic transcripts and cell type specific markers. We then directly
investigate the functional relevance of molecular rhythm ablation in specific striatal cell types during opioid self-
administration and sleep physiology and assess the impact of opioids on cell type-specific molecular rhythms in
mice in Aim 3. The findings from our proposal will resolve molecular rhythm alterations at the cell type-specific
level in the brains of subjects with OUD to begin to identify the mechanisms underlying the relationships between
circadian rhythms and OUD in the hopes of progressing towards strategies that target the circadian system in
the treatment of OUD.

Public health relevance
PROJECT NARRATIVE Opioid use disorder is a highly prevalent and devastating disorder, and emerging evidence from epidemiological and clinical studies have provided strong evidence for an association between sleep alterations, circadian rhythm disruptions, and opioid use disorder. This proposal will identify transcriptional rhythm alterations in the brains of people with opioid use disorder at the single cell level within subregions of the striatum, major neural substrates of reward and motivation. Preclinical models will be used to further define mechanism across circuit, cellular, and molecular levels, which will provide new insights into the putative mechanisms of opioid use disorder, with the potential of opening the door to development of new circadian-dependent therapeutic strategies.